Role of PROKR2 Neurons of the Amygdala in Reproductive Function

Project Summary
Kallmann Syndrome (KS) is characterized by infertility and anosmia due to deficiency in gonadotropin-
releasing hormone (GnRH) neuronal migration and olfactory bulb dysgenesis. Genetic studies have revealed
that KS is caused by loss-of-function mutations in several genes including the prokineticin receptor 2 gene
(PROKR2) observed in 10% of KS patients. Mice with global deletion of Prokr2 replicate the phenotype of KS
patients displaying olfactory bulb dysgenesis, impaired GnRH neuronal migration and infertility. Whereas the
role of PROKR2 during development is defined, little is known about PROKR2 neurons in adult reproduction.
PROKR2 mRNA and the mRNA for its ligand are highly expressed in reproductive control sites of the adult
mouse brain. Despite normal GnRH neuronal migration, heterozygous mice for Prokr2 loss of function mutation
display longer estrous cycles compared to wild type littermates. Similarly, humans with PROKR2 mutations
have a normal olfactory system but decreased fertility suggesting reproductive deficits independent of normal
olfactory bulb morphogenesis and GnRH neuronal migration. However, the neural basis for PROKR2 role in
adult reproduction is unknown. We recently developed a PROKR2-Cre mouse model in which Cre
recombinase is driven by the Prokr2 promoter. With this mouse model, we mapped the distribution of PROKR2
expressing cells in the brain of both sexes. PROKR2 mRNA and GFP+ cells were highly expressed in
subdivision of the medial amygdala in a sexually-dimorphic pattern. Male mice have higher PROKR2-Cre in the
amygdalohippocampal area (AHi, also called posterior nucleus of the amygdala) whereas females have higher
PROKR2 in the posterodorsal subdivision of the medial nucleus of the amygdala (MeApd). Both the MeApd
and the AHi show dense expression of sex steroid receptors and play important role in reproductive function
and associated behaviors. We hypothesize PROKR2-Cre neurons of the MeApd are necessary for typical
control of female reproductive function (including estrous cyclicity), whereas PROKR2-Cre neurons in the AHi
have a role in male reproduction. In two aims, we propose to map the neuronal projections of MeApd PROKR2
neurons in females and AHi PROKR2 neurons in males. We will also determine if PROKR2 neurons respond
to opposite sex odors. Lastly, we will use chemogenetic technology, i.e. the designer receptors exclusively
activated by designer drugs (DREADDs) to activate or inhibit PROKR2 neurons of the MeApd in females and
of the AHi in males. We will determine if activation of these neurons increases circulating reproductive
hormones and if inhibition of these neurons blocks the rise in reproductive hormones observed after exposure
to opposite sex odors. Our studies will define a role for PROKR2 neurons in subdivisions of the medial
amygdala, an important site of socio-sexual inputs and reproductive neuroendocrine responses in rodents and
primates, including humans. Upon completion, we expect our studies will contribute to the understanding of the
reproductive deficits associated with PROKR2 mutations.